Biomarkers of lung cancer risk

Project 2 – Biomarkers of lung cancer risk
Project Summary / Abstract
The US National Lung Cancer Screening Trial (NLST) demonstrated in 2011 that screening with computed
tomography (CT) scans can reduce lung cancer mortality by 20%, but with important costs including a high
false-detection rate of 95%. The study also indicated important differences in the benefit of screening in
different participant groups as defined by their underlying risk of lung cancer, thus highlighting the urgent need
to develop improved risk prediction models for identifying eligible subjects to screen.
Biomarker studies of lung cancer have reported a wide range of markers that appear strongly indicative of an
individual's underlying risk of developing a cancer that may be combined with information afforded by
traditional questionnaire based risk factors, in particular history of tobacco exposure. We hypothesize that a
comprehensive and extensively validated risk prediction model that incorporates risk-informative circulating
biomarkers has the potential to substantially improve existing risk prediction models, and our pilot data on a
limited set of risk biomarkers strongly supports this hypothesis. Our project will focus on systematically
assessing a comprehensive panel of biomarkers of lung cancer risk that have been implicated in previous
studies, and evaluate the extent to the extent to which they can improve risk prediction. This will be achieved
by bringing together data from ongoing large-scale biomarker studies, and conducting a comprehensive de
novo analysis of promising risk biomarkers within the Lung Cancer Cohort Consortium (LC3).
We will evaluate a wide range of promising risk biomarkers implicated in lung cancer by us or other research
groups, including miRNAs, metabolic, immune, and protein biomarkers, as well as epigenetic markers. The
initial stage will involve assaying a panel of Promising risk biomarkers at a centralized laboratory for 850 case-
control pairs from three prospective cohorts from the US, Europe and Asia, with subsequent large-scale
validation of the most informative markers in another 16 prospective cohorts from the LC3 consortium,
including 1,750 additional case-control pairs. The versatility of the individual LC3 cohorts will also allow us to
thoroughly assess important US minorities, including African American and Hispanic subjects. All lung cancer
cases that will be included were diagnosed within 5 years of blood collection. We expect that this will result in
establishing a distinct panel of validated and informative risk biomarkers for use in lung cancer risk prediction
models, which will be further validated in CT screening studies in collaboration with Project 3.

Public health relevance
Project 2 – Biomarkers of lung cancer risk Project narrative Extensive pilot data strongly supports the use of biomarkers in lung cancer risk prediction models. Within Project 2 we will systematically evaluate a comprehensive panel of promising risk biomarkers using pre- diagnostic blood samples. This will result in a selected panel of biomarkers of lung cancer risk that will be incorporated in risk prediction models, and used to identify those subjects most likely to benefit from CT- screening.